Structural basis for allosteric regulation of RyR1

PROJECT SUMMARY/ABSTRACT:
Ryanodine receptor-mediated calcium release plays an essential role in muscle contraction, and disruption of
calcium homeostasis in excitable tissues caused by RyR-mediated calcium leak causes several genetic
diseases, as well as contributing to the progressive loss of muscle function that occurs with aging. RyRs are
tetrameric ion channels of unusually large size, with each subunit bearing a large cytosolic region that acts as a
scaffold for the binding of allosteric modulators, which regulate the channel by binding at sites far from the
transmembrane pore. The mechanistic basis of long-range allosteric modulation of RyR1 activity is not well
understood. Understanding how allosteric regulators modulate RyR1 will both inform our understanding of RyR
in a physiological context, and facilitate the development of molecules that target the channel to treat RyR1
related diseases. The goal of our proposal is to understand the structural mechanism of action of RyR1 allosteric
modulators using single particle cryogenic electron microscopy (cryo-EM), complemented by functional analysis.
We will investigate calmodulin and dantrolene as examples of long-range allosteric modulators which are
endogenous protein binding partners and small molecule ligands, respectively. We will tackle this goal from three
directions. In Aim 1, we seek to obtain a complete atomic model of RyR1, including of the peripheral domains
where allosteric modulators bind, which have largely eluded sequence assignment due to their flexibility and
mobility. We will apply a combination of symmetry expansion and masked refinement to generate a combined
reconstruction with improved local resolution in peripheral regions, as well as explore optimization of sample
preparation to obtain a more homogeneous particle set. In Aim 2, we will obtain structures of RyR1 in multiple
functional states in complex with calmodulin and apocalmodulin, and to use single channel recordings of mutants
of both calmodulin and RyR1 to test hypotheses arising from these structures. In Aim 3, we will investigate the
mechanism of allosteric inhibition of RyR1 by dantrolene, by first structurally identifying the dantrolene binding
site, and then examining the interdependence between inhibition by dantrolene and regulation by calmodulin,
magnesium and ATP. Our research will broadly impact the field by unraveling the structural basis of allosteric
regulation of an essential ion channel, RyR1. Structural characterization of the dantrolene binding site may lead
the way to structure-based design of new RyR1 targeting therapeutics for the treatment of malignant
hyperthermia and RyR1-related myopathies.

Public health relevance
PROJECT NARRATIVE: Ryanodine receptors facilitate the coupling of nervous excitation to muscle contraction, by releasing calcium ions from intracellular stores in response to depolarization of the plasma membrane. This is an essential process of fundamental importance to human physiology, and dysregulation of intracellular calcium release in skeletal muscle causes diseases such as malignant hyperthermia, central core disease and RyR1-related myopathies. We seek to understand this process at a molecular level, by interrogating the structural and functional regulation of RyR1 by molecules that modulate channel activity allosterically, including the therapeutic dantrolene.